COMPARE FED AND FASTED GASTRIC AND SMALL BOWEL MOTILITY IN NORMAL SUBJECTS

To establish normal ranges and compare fed and fasted gastric and small bowel radionuclide and motility parameters in normal subjects. This data will be used as a reference in studying patients with delayed gastrointestinal transit.